Streptococcus species as potential therapeutics for oropharyngeal squamous cell carcinoma

Project summary/Abstract
Although different treatments such as chemoradiation and immune checkpoint inhibitors (ICI) are used
to treat oropharyngeal squamous cell carcinoma (OSCC), the 5-year survival rate in advanced OSCC is around
40%. These treatment options are costly and induce side effects in many patients, therefore, treatments that are
effective, affordable, and cause fewer short- and long-term therapy-related health problems are needed to
increase the survival rate while improving the quality of life of these patients, especially in minority populations.
Oral commensal non-pathogenic Streptococcus species such as Streptococcus salivarius (S. salivarius)
and S. vestibularis are important to maintain oral health, in part by decreasing pro-inflammatory cytokines such
as IL-6 and IL-8, known to be associated with cancer progression. Also, we have preliminary data, obtained by
students in the lab, demonstrating that (i) S. salivarius cell-free supernatant induces oropharyngeal cancer cell
death, (ii) intratumoral injection of S. salivarius decreased the growth of HPV+ oropharyngeal tumors, leading to
increased intratumoral infiltration of T cells, and (iii) application of S. salivarius in the oral cavity induced the
activation of CD8+ and natural killer cells in tongue tumor-bearing mice. Therefore, we hypothesize that S.
salivarius will stimulate anti-tumor immune responses and/or modulate the microbiota to promote oropharyngeal
tumor regression. Our interdisciplinary team with experience in immunology, microbiology, cancer biology and
student mentoring will allow us to achieve our overall objective to identify the anti-cancer and immunomodulatory
properties of Streptococcus species within the tumor microenvironment and train the next generation of scientists
in cancer immunology. To test our hypothesis, we will develop the following specific aims: (1) Identify oral
commensal Streptococcus species that affect oropharyngeal squamous cell carcinoma survival, proliferation and
migration, (2) Identify anti-tumorigenic functions induced by oral commensal Streptococcus species in preclinical
models for oropharyngeal cancer. The long-term goal of this project is to develop microbial therapeutics for
OSCC to address the overarching need to identify affordable cancer treatments and improve the prognosis of
OSCC patients while reducing patient morbidity. Importantly, students will be trained in the establishment of
preclinical cancer models, mammalian and bacterial cell culture assays and immunological assays to develop
the next generation of immune-oncology scientists.

Public health relevance
Project Narrative In this project, Ph.D. and B.S. students will identify oral commensal non-pathogenic Streptococcus species, such as S. Salivarius and/or S. vestibularis, capable of decreasing cancer cell survival and modulating the tumor immune microenvironment during oropharyngeal squamous cell carcinoma (OSCC). Students will be trained in cancer immunology and cancer biology to achieve our long-term goal of developing microbial therapeutics for OSCC.